Otic Guidance

Project Summary / Abstract
The ﬁrst aim of this research proposal is to use single-cell transcriptomics to describe the changes in gene
expression that happen during otic guidance from pluripotent stem cells. It builds on known principles of
inner ear development and utilizes single-cell RNA-Seq and computational modeling for extracting the
diﬀerentiation pathway of cells towards non-neural ectoderm, pre-placodal ectoderm, and ultimately otic
induction and the sensory hair cell lineage. In a second aim, it is proposed to comparatively investigate the
distinct steps when otic guidance from embryonic stem cells fails, which is a common problem. The
generation of inner ear cells from embryonic stem cells is an unreliable enterprise and has hampered research
for more than a decade. Computational comparisons of gene expression changes in successfully guided
inner ear lineage cells with lineages that stray from otic diﬀerentiation will result in the identiﬁcation of speciﬁc
signaling pathways that contribute to cell diﬀerentiation failures. Based on computational modeling, testable
hypotheses will be generated and experimentally validated. The ultimate goal of the proposed research is the
elimination of experimental variations of otic guidance from stem cells towards establishing a reliable otic
guidance protocol that can be widely utilized by many laboratories.

Public health relevance
Project Narrative The generation of inner ear cells from pluripotent stem cells is an essential step for eﬃcient drug screening and evaluation of inner ear disease without direct biopsy of a patient's inner ear. The proposed research aims to identify the critical steps whose modulation will make the generation of inner ear cells from pluripotent stem cells more eﬃcient compared to current technology.